ALTERED CONTROL OF PERIPHERAL RESISTANCE AFTER PROLONGED BEDREST

This project studies the effects of prolonged bedrest (14 days) on orthostatic intolerance. Specific measurements include sympathetic disactivity, plasma norepinepherine concentration spill over and leg vascular resistance during head-up tilt. We are also examining cardiac output and functions in the same individuals.